Developing UPR inhibitory KIRAs into oral antidiabetic beta cell-sparing drugs

Type 1 diabetes (T1D) is a chronic autoimmune disease characterized by hyperglycemia due to progressive immune-mediated destruction of pancreatic beta cells. Recent work from our laboratories has shown that hyperactivation of the unfolded protein response (UPR) to ER stress in the immune-targeted beta cells may be a critical early event in the development of T1D. We have developed novel pharmacological reagents that allow us to manipulate components of the UPR. Importantly, these small molecules delivered to NOD mice can efficaciously prevent and even reverse diabetes in this T1D model. Thus, in this collaborative grant we will capitalize on the complementary expertise of the investigators to optimize these lead molecules for oral delivery, conduct proof of concept studies, and perform key enabling steps needed to advance these candidates into the clinic for treating human patients with T1D.

Public health relevance
Type 1 diabetes (T1D) is a chronic autoimmune disease characterized by hyperglycemia due to progressive immune-mediated destruction of pancreatic beta cells. The high protein secretion burden of beta cells predisposes them to significantly higher levels of endoplasmic reticulum (ER) stress compared to non-secretory cells. Recent work from our laboratories has shown the activation of stress response pathways such as the unfolded protein response—UPR—may be an initial causal event in the development of T1D. In this collaborative MPI grant we capitalize on the complementary expertise of the investigators and pharmacologically target the UPR with novel chemical matter called KIRAs as new therapeutic approaches for T1D.